Pathomic Predictors of Prostate Cancer Progression

Abstract
Recent studies suggest that in the U.S. prostate cancer is over-detected and over-treated resulting in
significant morbidity and financial costs. These problems are the product of poor sensitivity and specificity
serum Prostate Specific Antigen (PSA) as a screening tool, leading to unnecessary biopsies that find small and
predominantly indolent prostate tumors. While many prostate cancers should be managed with active
surveillance, uncertainties surrounding available clinical tools of aggressiveness (such as PSA, Gleason score
and clinical stage) will often drive patients and physicians to treatment. Attempts to improve prognostication
using candidate biomarkers, mostly discovered from genomic analyses of large pieces of cancers, have had
few successes, and available molecular tools provide only modest prediction, at best.
An alternative to the genomic driver focus is that a combination of molecular events, under the influence of
the tumor microenvironment, drive tumor’s molecular evolution and progression. Consequently, analysis of
tumor characteristics detectable in pathomic data, such as heterogeneity of expression subtypes, amount of
stroma, extent of microenvironmental heterogeneity, extent of immune infiltration, or extent of hypoxia, may
ultimately lead to better patient stratification. Our proposal fundamentally centers around the most critical
clinical question in early prostate cancer that is the basis for clinical decision making: Can we identify
proteomic, imaging, and/or microenvironment features that distinguish those aggressive cancers that
will progress to cause harm from benign cancers that can be safely monitored by watchful waiting?
To examine the links between the heterogeneity of early, screen-detected prostate cancers and likelihood of
progression, we will interrogate a retrospective set of 225 prostatectomy patients. In Aim 1, we will use GE’s
hyperplexed immune-pathology platform (Cell DIVE) to profile over 50 proteins at the cellular and subcellular
level along with matrix components that define the microenvironments with the cells present in this matrix. In
Aim 2, we will focus on single-cell level data and systematically extract the prevalence of the diverse cell
subtypes found within these tumors. Cells will be typed along traditional axes (e.g. epithelial, CD4+ T-cells). In
addition, we will use molecular and structural characteristics to define novel subtypes. Features associated
with cell types (e.g. existence, prevalence, diversity) will be used alone and in combination with Gleason
grading to distinguish patients with aggressive tumors that are likely to progress. Aim 3 will focus on
neighborhood and regional analyses, particularly on developing approaches to extract tumor
microenvironmental characteristics that have demonstrated linkages to progression (hypoxia, stromal
reactivity, immune cell patterning). Using a diverse set of these features, alongside deep learning techniques
on primary images, we will develop classifiers distinguishing aggressive and benign tumors. Finally, in Aim 4
we will validate classifiers in large cohorts.

Public health relevance
Project Narrative Our proposal fundamentally centers around the most critical clinical question in early prostate cancer that is the basis for clinical decision making; namely, can we identify proteomic, imaging, and/or microenvironment features that distinguish those aggressive cancers that will progress to cause harm from benign cancers that can be safely monitored by watchful waiting?